Interferon-inducible cell-autonomous immunity to cytosolic bacterial pathogens

Human cells including epithelial cells are equipped with cell-autonomous host defense programs providing
protection against intracellular pathogens. These host protective programs are controlled in a temporal and
spatial manner and respond to extracellular cues including pro-inflammatory cytokines released by professional
immune cells. Arguably, the most potent inducer of antibacterial cell-autonomous host defense is lymphocyte-
derived interferon-gamma (IFN). IFN-receptor signaling in human epithelial cells induces the expression of
hundreds of IFN-stimulated genes (ISGs) encoding antimicrobial proteins. While a few ISGs have been studied
in much detail, our understanding of most ISGs and their functions in host defense is limited. We recently
discovered a critical role for IFN-inducible guanylate binding proteins (GBPs) in cell-autonomous immunity to
Gram-negative bacterial pathogens invading the host cell cytosol. Human GBP1 is a cytosolically localized
member this GBP family and able to directly detect a central building block of the Gram-negative bacterial outer
membrane, i.e. lipopolysaccharide (LPS). Our previous work showed that GBP1, through these LPS interactions,
forms a multimeric microcapsule or coatomer surrounding Gram-negatives invading the host cell cytosol.
However, GBP1 binding to the bacterial surface on its own is neither bactericidal nor bacteriostatic, implicating
other GBP1-dependent co-factors required for sterilizing cell-autonomous immunity. Aim1 of our proposal will
explore a novel GBP1-dependent pathway that results in bacterial ubiquitylation, a well-established ‘eat-me’
signal that marks cytosolic microbial invaders for destruction. Our studies are multidisciplinary and include
biochemical approaches levering a novel in vitro GBP1-bacteria binding assay that we established. Using this
assay, we will directly assess how GBP1 promotes the recruitment of IFN-inducible host ubiquitin E3 ligases to
the surface of the Gram-negative cytosol-invading bacterial pathogen Shigella flexneri. S. flexneri is a human-
adapted enteric pathogen that causes dysentery and diarrheal deaths, especially in children in low- and middle-
income countries. Our preliminary data demonstrate that wildtype S. flexneri is resistant to GBP1-dependent and
-independent host-driven bacterial ubiquitylation. Therefore, in our second aim we will identify and characterize
a network of virulence factors used by S. flexneri to escape IFN-induced ubiquitylation and associated host
defenses. To define the physiological relevance of these antagonistic relationships between antibacterial ISGs
and counter-acting bacterial virulence mechanisms employed by S. flexneri, we will exploit a novel mouse model
of intestinal S. flexneri infections. Using ISG-deficient mouse lines established in our lab and, reciprocally,
infecting with S. flexneri mutants defective for virulence effectors targeting the same ISGs, we will determine the
physiological importance of GBP- and other ISG-driven host defenses and their evasion by S. flexneri for
bacterial pathogenesis and enteric disease.

Public health relevance
Infections with the enteric bacterial pathogen Shigella are the second leading cause of diarrheal deaths globally and the emergence of antibiotic resistant Shigella strains increasingly limits our ability to treat infections. Our studies will define novel anti-Shigella human immune programs that are inhibited by virulence factors produced by Shigella. Therefore, our studies will determine whether pharmacological targeting of these Shigella virulence factors has the potential to be used as as a novel treatment option for Shigellosis.